Nano-AB: An Innovative Nano Biomaterial for Rapid, Column-Free Antibody Purification

Project Summary
The protein purification market is critical to research and biopharmaceutical production, with monoclonal
antibodies (mAbs) comprising approximately 40% of total demand. This highlights a significant need for cost-
efficient, scalable, and high-performance purification technologies. Current approaches, such as agarose and
macro-porous resins, are hindered by the limitations of their microstructural bases. Agarose resins offer a large
liganded surface area, providing potentially high capacity, but suffer from small pores that significantly increase
residence time (RT), leading to prolonged processing. Conversely, macro-porous membranes facilitate short
RT by providing direct access to column ligands but sacrifice capacity due to their reduced liganded surface
area. These fundamental drawbacks reflect an unresolved contradiction in current materials and underscore
the need for innovation to enhance efficiency and reduce operational costs.
NanoBPI proposes a transformative solution by leveraging advanced polypeptide-based nano-biomaterials to
develop Nano-Beads (NanoAbs) charged with Protein A (NanoZ) and Protein G (NanoG) ligands. Unlike
traditional micro-dimensional resins, NanoAbs operate at the nanoscale, enabling a non-porous structure with
a larger total liganded surface area. This innovation not only addresses the limitations of agarose and macro-
porous membranes but also combines their respective advantages, resulting in superior purification
performance. In Phase I, we will focus on developing disposable NanoAbs specifically tailored for the research
market, where cost, scalability, and processing efficiency are critical. The NanoG variant fills a significant gap,
as the current options are limited to agarose beads, which are characterized by prolonged RT and inefficiency
in mAb purification.
Our Phase I objectives include developing NanoG with a binding capacity of 50–60 mg/mL and overall
productivity representing a 4–5-fold improvement over current agarose products. Additionally, we aim to
optimize the manufacturing processes for NanoZ and NanoG to reduce downstream processing (DSP) time by
at least threefold and achieve a 1.3–1.4-fold increase in mAb purification productivity. These advancements
align closely with the objectives of NIH NOSI (NOT-EB-24-001), which emphasizes advancing paradigm-
shifting biomaterials-based technologies leading to commercialized products. These advancements will
position NanoBPI as a competitive force in the $11.7 billion DSP market, addressing the rising demand for
therapeutic proteins and mAbs with cost-effective and scalable solutions tailored to both research and
pharmaceutical sectors.

Public health relevance
Public Health Relevance Statement This project aims to revolutionize monoclonal antibody purification by developing cost-effective and highly efficient nano-biomaterial-based purification tools. By addressing the limitations of current agarose and macro- porous resins, these advanced Nano-Beads will streamline the production of therapeutic antibodies, reducing costs and enhancing accessibility for research and biopharmaceutical applications, ultimately benefiting public health. Furthermore, this proposal aligns with the purpose and objectives of NIH NOSI (NOT-EB-24-001), which focuses on advancing paradigm-shifting biomaterials-based technologies leading to commercialized products, ultimately benefiting public health.